RhoFED AA-SCCC

PROJECT SUMMARY/ABSTRACT
The causes, pathogenesis, diagnosis, treatment, and prevention of allergic diseases and asthma are major
areas of emphasis for the National Institute of Allergy and Infectious Diseases (NIAID). NIAID pursues
research on allergic diseases and asthma by supporting investigator-initiated research projects and national
networks of research centers. The NIAID-funded Allergy and Asthma Statistical and Clinical Coordinating
Center (AA-SCCC) provides a broad range of support critical for design, development, execution, and analysis
of clinical research in allergic diseases and asthma. The major clinical research programs supported by the
AA-SCCC include the Atopic Dermatitis Research Network (ADRN), Consortium for Food Allergy Research
(CoFAR), Childhood Asthma in Urban Settings Clinical Research Network (CAUSE), and Immune Tolerance
Network (ITN). These networks currently lack a platform accessible to the public for showcasing their projects
and disseminating their valuable findings. Recognizing the importance of community engagement, the AA-
SCCC advocates for the establishment of a comprehensive website accessible and targeted to the public that
will serve as a hub for the AA-SCCC's overarching objectives, offering direct links to dedicated pages for each
network. Establishing a public-facing website for the AA-SCCC will enable the supported networks to exhibit
their ongoing studies, actively promote study recruitment, spotlight successful outcomes, and share findings
with the broader community.

Public health relevance
PROJECT NARRATIVE The NIAID-funded Allergy and Asthma Statistical and Clinical Coordinating Center (AA-SCCC) provides a broad range of support for research in allergic diseases and asthma, including for the following major clinical research programs: the Atopic Dermatitis Research Network (ADRN), Consortium for Food Allergy Research (CoFAR), Childhood Asthma in Urban Settings Clinical Research Network (CAUSE), and Immune Tolerance Network (ITN). These networks currently lack a platform accessible to the public for showcasing their projects and disseminating their valuable findings. This additional funding would establish a public-facing website for the AA-SCCC that will enable the supported networks to exhibit their ongoing studies, actively promote study recruitment, spotlight successful outcomes, and share findings with the broader community.